Fenway Community Health Center, Inc., Site Consortium - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT The Fenway Institute
The Fenway Site Consortium (FSC) is designed to support, as one of the Site Consortiums, the application of
Westat to serve as the Operations and Coordinating Center (OCC) in the next funding cycle of the Adolescent
Trials Network (ATN) (RFA HD 23-021). The FSC will be based at The Fenway Institute (TFI) of Fenway
Health (FH), a Federally Qualified Health Center in downtown Boston, Suffolk County. The long- term
objectives of this proposal are to conduct the research projects identified by the ATN Executive Committee
(EC) and Scientific Leadership Center (SLC), and optimize recruitment, monitoring, and retention of HIV-
positive and at-risk youth into clinical trials designed to improve their health and to decrease HIV transmission
and acquisition. To facilitate this process, the FSC will include other key FH programs, including the health
center, which provides primary care for more than 9,500 youth 24 years of age and younger, with a focus on
the affiliated Sidney Borum Health Center, which specializes in the care of sexual and gender minority youth,
and the Public Health Programs that include programs focusing on health system navigation, drop in
HIV/sexually transmitted infection (STI) screening, harm reduction programs for PWID, and programs
addressing social determinants of health (e.g., housing and legal support). Additionally, we will utilize our
grants management and contract negotiation teams to ensure optimal execution of all logistical and budgetary
aspects of the grant. A primary member of the consortium will be JRI Health, which administers multiple
programs for HIV-infected and at-risk youth in Boston and throughout Southern New England, including
Providence, Worchester, and Southern New Hampshire. Other consortium members will include the Boston
Public Health Commission, Boston Public Schools, the Massachusetts Department of Public Health (DPH), and
collaborators in other local programs serving HIV-positive and at-risk youth. These partnerships will enable us
to meet the proposed research goals of the SLC. In this project, we aim to: (1) Convene regular meetings of
key consortium members to discuss new and ongoing protocols, to solicit their input regarding best practices
for recruitment, community engagement, and participant retention, and for community education; (2) Convene
a youth community advisory board (YCAB), which will provide input into youth priorities related to the work of
the ATN, and guidance regarding best practices for community engagement and education; (3) Ensure optimal
communication between local members of the FSC and the OCC and scientific leadership through routine
meetings of local consortium members and engagement of consortium members in meetings convened by the
OCC; (4) Actively participate in all relevant ATN activities, including providing site representatives to
governance committees of the ATN, and site investigators to represent the FSC on ATN protocols.